The Role of the GATA2 Interactome in Erythropoiesis

PROJECT SUMMARY
My goal is to become an exceptional tenure track physician-scientist focused on identifying diverse and
unexpected cellular factors and pathways that regulate hematopoiesis, and elucidating the molecular
mechanisms of their function. This K08 Mentored Clinical Scientist Research Career Development Award would
provide me with the necessary support to complete a rigorous and structured training program and establish
myself as a successful independent investigator. My proposed research focuses on the transcription factor
GATA2, which is critical for emergence of the blood and bone marrow during development and maintenance of
the bone marrow stem cell compartment in adults. Clinically, germline mutations in GATA2 cause the poorly
understood GATA2 Deficiency Syndrome. I hypothesize that there is a diverse and undiscovered network of
proteins that interface with GATA2 to modulate the process of hematopoiesis. To this end, I have developed
uniquely effective and specific anti-GATA2 antibodies that react with mouse and human GATA2 and utilized
these to identify 153 putative GATA2 interactors in erythroid precursor cells. In this proposal, I plan to establish
how these proteins function in GATA2 biology and in human and mouse erythropoiesis. I am supported in these
efforts by a team of accomplished investigators and mentors who constitute my Research Advisory Committee:
my primary mentor Dr. Emery Bresnick, an international expert in red cell biology, hematopoiesis and GATA
factors; Dr. Igor Slukvin, an international expert on induced pluripotent stem cells and their application for basic
and applied science; Dr. Jing Zhang, an internationally recognized expert on malignant hematopoiesis; and Dr.
Andreas Friedl, Chair of the UW-Madison Department of Pathology and Laboratory Medicine who has guided
my career development and organized my recruitment. I will also enjoy technical support from Dr. Ying Ge,
Professor of Cell and Regenerative Biology and Director of the Human Proteomics Program at UW-Madison.
These studies have the potential to radically expand our understanding of how a small number of transcription
factors accomplish the wide variety of functions necessary to successfully establish and maintain a healthy bone
marrow. The results will form the foundation for independent studies and future R01 proposals. The mentoring
and career development that I receive during the course of this research will prepare me to excel as a physician-
scientist and integrate me into the greater hematology community.

Public health relevance
PROJECT NARRATIVE Disorders of the blood and bone marrow are of great public health significance. The transcription factor GATA2 is responsible for emergence of the blood and bone marrow during development and maintenance of the bone marrow stem cell compartment in adults, while germline mutations in GATA2 predispose to immunodeficiency and bone marrow failure. Understanding the factors that interface with GATA2 to regulate its functions on chromatin will help us elucidate its role in promoting a healthy bone marrow and inform future therapies for conditions involving the blood and bone marrow.